Implementation Science and Equity: Pragmatic Implementation Science Methods (PrISM) Core

PROJECT SUMMARY/ABSTRACT: PRAGMATIC IMPLEMENTATION SCIENCE METHODS (PrISM) CORE
Regardless of their research training or inherent talent, the learning curve for new investigators in
implementation science can be steep. The PrISM Core will provide COBRE and other KUMC investigators the
coordinated, interdisciplinary support that is critical to success in this complex field. PrISM’s ‘team science’
approach will increase the likelihood of successful execution of research projects and better prepare Project
Leads for working in the collaborative research environment that is critical to implementation science.
Aim 1. Establish an Implementation Science methods Core bringing together expertise in implementation
science theory and methods and leveraging the principles of team science to seamlessly integrate expertise in
biostatistics, medical informatics, mixed methods research, and health equity research. The PrISM Core will
work closely with the CEO core to provide researchers with access to research sites and clinical data needed
to support pragmatic implementation research that advances health equity.
Aim 2. Support COBRE Project Leads in project conceptualization, design, execution, and analysis,
and plans for future research. We will use an adaptation of Proctor’s classic model of implementation
research to create a framework for supporting Project Leads through each step of equity-focused
implementation research, including: describing existing disparities in treatment, developing implementation
strategies, analyzing outcomes, reporting results, and designing new, innovative research proposals to extend
or disseminate findings from COBRE-supported work.
Aim 3. Foster new applications and implementation science methods to address health equity. PrISM
will work with the Administrative Core to identify and support new investigators and advance implementation
science methods, including methods that address unique issues in rural, minority and other underserved
communities. PrISM will also continually scan the field to identify critical gaps in equity-focused
implementation research in order to help prioritize COBRE efforts.
Aim 4. Collaborate with the Administrative Core to evaluate PrISM performance. The PrISM core
addresses a previously unmet need at the University of Kansas Medical Center for an integrated team focused
on implementation science. The PrISM Core will increase institutional and regional capacity to conduct high
quality implementation research, will make research projects more pragmatic, and as a result will increase the
COBRE’s potential for sustained and widespread impact on the field.